Revealing activity signatures of early life adversity in the basolateral amygdala driving risky decision making

PROJECT SUMMARY
Traumatic events experienced early in life can shift the behavioral repertoire in adolescence and adulthood,
causing increases in risk seeking behaviors. These risky behavioral changes can lead to consequences such as
motor vehicle accidents, increased sexual behaviors, and drug and alcohol abuse. The likelihood of making a
risky decision is highest in adolescence, when unfortunately, the consequences may be the most severe and life
altering. Understanding the ways in which early life adversity (ELA) increases adolescent propensity for risk
taking is essential to preventing this maladaptive response, which can lead to harmful outcomes. ELA alters
cellular function and activity in areas responsible for control of risky behaviors, including the basolateral
amygdala (BLA), nucleus accumbens (NAc), and prefrontal cortex (PFC). The connectivity between these areas
is responsible for assessing threat, responding to novel stimuli, and assessing valence, all of which are essential
for safety related behaviors. The BLA is particularly poised to control risky behaviors and is also vulnerable to
ELA related changes, including increases in neuronal excitability, making the BLA an incredibly valuable region
to study when investigating ELA induced risk taking. Thus, examining activity changes to the BLA during ELA
and manipulating ELA-impacted BLA ensemble activity during a risky decision-making task (RDT) will uncover
a targetable neural mechanism underpinning adolescent maladaptive behavior. The RDT is a suitable task to
assess risk taking because it measures an animal’s probability to choose a risky reward under variable
probabilities of known risk, which is a shared core feature of risky decision making across species and therefore
provides translational insight. In my previous work in the Brenhouse lab, I use a maternal separation (MS) model
to assess adolescent changes in anxiety-like behaviors following chronic BLA inhibition. I found that rats exposed
to MS exhibited decreased anxiety behaviors in adolescence as evidenced by increased exploratory behavior,
which was contrary to my original hypothesis. This led me to design the current proposal, as I hypothesize that
MS can drive increased risk taking in adolescence by recruiting BLA neuronal populations to be
hyperexcitable. In Aim 1, I will test for ELA-driven changes to BLA cellular activity profiles by using RNAscope
to examine increased immediate early gene expression in glutamatergic and GABAergic cells within the BLA
following various time points of MS or control rearing. In Aim 2 I will tag cells with an activity dependent viral
vector during MS, and then optogenetically excite or inhibit these cells during the RDT in order to test the ability
of MS-affected cells to drive changes to risky behaviors. Ultimately the resulting discoveries from this project will
contribute to the understanding of how ELA alters risk taking behaviors in adolescence and inform strategies to
develop treatments for disordered behaviors involving increased risk seeking. The training I will receive through
this F31 award will aid in my goals of becoming a well-rounded independent researcher focused on studying
animal models of disease following ELA.

Public health relevance
PROJECT NARRATIVE Exposure to early life adversity (ELA), such as maternal separation, increases the likelihood of engaging in increased risky behaviors, such as drug and alcohol abuse, and this is especially true during the adolescent time period. ELA is also capable of altering cellular function and connectivity in many brain areas involved in risky behaviors, including the basolateral amygdala; therefore, we will determine how ELA alters the activity of basolateral amygdala cells, and how manipulating these affected cells can alter risky decision making in adolescence. The results of this project will lay a foundation for the refinement of preventing increased risk taking in adolescents following ELA.